REACH Center Community Engagement Core

PROJECT SUMMARY - COMMUNITY ENGAGEMENT CORE
The REACH Center Community Engagement Core will develop and apply strategies for catalyzing the cocreation
of REACH Center climate and health research projects and study outputs in support of policy
decision-making and implementation. By serving as a bridge between REACH Center academic
investigators and multiscale stakeholders, the Core will build trust, transform solutions, and speed
implementation through integration of community input and involvement into Center activities,
including its investigator-initiated research projects, pilot projects, and student fellowships. The CEC will
engage with a variety of actors and end-user communities who are positioned to take health-protective
actions, including those at all levels of governance and facets of civil society. This includes civic
organizations that represent communities such as mayoral associations, regional government
associations, health and hospital systems, environmental organizations, and disease-focused
associations, as well as federal, state, and local governmental agencies. Rather than focusing on a single
or small set of community groups, the CEC focuses on providing tools and frameworks that build
capacity for developing targeted, collaborative teams between investigators and end-users that have
the knowledge, skills, experiences, and agency to create change. The Core will initiate and facilitate codesign
strategies for developing and applying the outputs of scientific investigations that inform healthprotective
solutions for climate-sensitive risk factors. To do so, the Core will create researcher/end-user
teams by matching REACH Center research project and pilot award academic investigators with relevant
community groups, advance scientific literacy and awareness of environmental risk factors and human
health links through communication and outreach strategy support, and integrate community
engagement across REACH Center Cores. The Core will also evaluate formative REACH Center
engagement and communication strategies between investigators and potential end-users of research
project outputs in the co-generation of policy-relevant research questions and products to further
advance to a Center of Excellence. This will be accomplished by developing a set of evaluation metrics
for select research and pilot project teams based on shared objectives of researchers and end-users, and
identifying successful engagement processes and infrastructure needs for further catalyzing use of
REACH Center research products in federal, state, and local policy contexts. The Community
Engagement Core will empower REACH Center investigators to develop community-engagement skills
and access networks of end-users that allows for the application of scientific insights and tools in policy
decision-making, design and implementation. These activities will establish a pipeline of research
activities capable of generating community-centered findings and supporting the implementation of
durable health-protective policy solutions for climate-sensitive risk factors.